CONTINUOUS GLUCOSE MONITORING SYSTEM

We will test the hypothesis by contrasting every five minute measurements of subcutaneous glucose (MiniMed CGMS) and blood glucose during hyperinsulinemic euglycemic, hypertglycemic, hypoglycemic and euglycemic clamps in patients with Type 1 Diabetes Mellitus.